mTOR-Mediated Desaturation of Fatty Acids in Hepatic Insulin Resistance.

Discharged members of the US Armed Services are at an increased risk of metabolic disease which is
exemplified by the prevalence of type 2 diabetes mellitus (T2DM) affecting an estimated 1/3 of all VHA
patients. A key defect in the etiology of T2DM is the inability of insulin to suppress hepatic glucose production,
or hepatic insulin resistance. Alterations in hepatic lipid metabolism precede hepatic insulin resistance and are
regulated largely by mitochondrial fatty acid oxidation (β-oxidation) and, in particular, the ability to maintain
effective metabolic flexibility under different dietary states. Previous work has implicated mechanistic target of
rapamycin (mTOR) as a mediator of this process through the regulation of β-oxidation. However, our
preliminary work found an interesting dichotomy; inhibition of mTOR promotes β-oxidation of fatty acids when
there is a prevalence of saturated fatty acids substrates available but in contrast impairs β-oxidation when
unsaturated fatty acids are the primary dietary lipid sources. That is, unsaturated fatty acid catabolism by β-
oxidation is not complete in the context of low mTOR singaling. β-oxidation of unsaturated fatty acids requires
accessory enzymes to desaturate for use as mitochondrial substrates. Because the development of insulin
resistance is linked to dysregulation in metabolic flexibility, we propose that mTOR-mediated regulation of this
process is a key to maintaining hepatic insulin sensitivity and preventing metabolic disease.
The long-term goal of this proposal is define a relationship that could be central to the development of
hepatic insulin resistance. This metabolic dysfunction is highly prevalent among Veterans and is a significant
long-term healthcare issue due to increased risk of developing additional pathologies associated with this
condition, including non-alcoholic fatty liver disease and hepatocellular carcinoma. Treatment and prevention
options will significantly reduce the health burden of Veteran patients as well as Veterans Health
Administration costs associated with treatment. Our overall hypothesis is that mTOR regulates the response to
dietary fatty acids through its regulation of β-oxidation accessory enzymes and that dysfunction in this pathway
leads to hepatic insulin resistance. Our rationale for this study is that understanding how this pathway
regulates nutrient usage under metabolic stress will serve as a means to define new therapeutic targets to be
utilized for treatment and prevention of metabolic disease in Veterans.
We test this hypothesis using both pharmaceutical and genetic manipulation of mTOR signaling and the
rate limiting β-oxidation accessory enzyme 2,4 Dieonyl-CoA reductase (DECR1) in primary hepatocytes and
mouse models in experimental aims that link this pathway with mitochondrial energetic function and
metabolism. In aim 1, we test whether mTOR signaling has direct impact on the activity of DECR1 with a
functional outcome on fat oxidation. In aim 2, we then test whether β-oxidation accessory enzymes in mice
play a significant role in the development of hepatic insulin signaling under metabolic stress using a novel
DECR1 knockout mouse model. In particular, we test the metabolic and mitochondrial response to metabolic
stress from changing dietary sources of fat. In aim 3, we address remodeling of the hepatic mitochondria as a
homeostatic mechanism to maintain metabolic flexibility and the potential role of β-oxidation accessory
enzymes in this process.
Hepatic insulin resistance is promoted by several factors including diet, genetics and liver pathology. By
clarifying a central pathway in the process through mTOR and β-oxidation accessory enzymes, our approach
will lead to breakthrough discoveries that will significantly enhance health research to help our Veterans.

Public health relevance
Discharged members of the US Armed Services are at increased risk of metabolic disease including type 2 diabetes. Hepatic insulin resistance plays a key role in this metabolic dysfunction and is a significant long-term healthcare issue to the VHA due to increased risk of developing additional pathologies and mortality. A key player in the development of hepatic insulin resistance is mechanistic target of rapamycin complex 1 (mTORC1) due to its ability to regulate lipid metabolism. Our preliminary data suggests that mTORC1 also plays a divergent role in the catabolism of unsaturated fatty acids leading to an overall hypothesis that mTORC1 regulates the ability of mitochondria to shift fatty acid substrate preference through catabolism of these fatty acids and that dysfunction in this pathway leads to hepatic insulin resistance. Our rationale for this study is that delineating the mechanisms of nutrient usage regulation by the liver will serve as a means to define new therapeutic targets for treatment and prevention of metabolic disease in our Veterans.